Actify! An mHealth mood management tool to improve population-level smoking cessation

PROJECT SUMMARY
Cigarette smoking is responsible for over 480,000 deaths annually in the US—nearly double the number of
drug overdose and alcohol-related deaths combined—making cigarettes the most deadly drug of abuse.
Although smoking rates have declined over the past 50 years, tobacco use remains a critical public health
problem, and more effective cessation interventions are needed. Depressive symptoms are a key barrier to
cessation for many and reduce the odds of cessation by as much as 50-60%. Despite this, standard cessation
treatments do not focus on reducing depressive symptoms as a means of supporting cessation. Doing so,
however, could increase treatment effectiveness. Behavioral activation (BA) is a proven intervention for
depression. Research suggests combining BA and standard cessation treatment may increase quit rates.
Delivering this intervention through a mobile health application (mHealth app) would also make the treatment
more accessible (smoking cessation apps are downloaded over 1 million times per year in the US alone),
thereby increasing its impact. To test this hypothesis, we developed Actify!, the first app-based cessation
intervention to combine BA with standard cessation support. In a rigorous, pilot randomized trial (n = 242),
Actify! had descriptively higher user satisfaction and quit rates than the National Cancer Institute’s (NCI)
QuitGuide app (e.g., 18.5% vs. 12.2% abstinence at 6 months). We now propose to conduct a fully-powered,
randomized controlled trial to evaluate the efficacy of Actify! relative to QuitGuide at 6 months post-
randomization (Aim 1), examine the moderating effects of pre-quit depression on 6-month cessation outcomes
(Aim 2), and evaluate the extent to which changes in behavioral activation and depressive symptoms mediate
these outcomes (Aim 3). This work is highly significant and innovative: (1) Actify! is the first standalone
mHealth intervention of any kind to actively target reducing depression and promoting smoking cessation
simultaneously; (2) strong preliminary evidence supports Actify!’s acceptability and efficacy relative to an active
standard care comparator, the NCI QuitGuide app; and, (3) mHealth apps offer a promising and cost-effective
modality for disseminating the intervention, if it is found to be effective. This project will also provide a definitive
test of whether Actify! is superior to QuitGuide and, therefore, warrants future dissemination. It will also provide
critical insights into our premise that addressing depressive symptoms with app-based BA can enhance
cessation for people with and without a history of depressive symptoms at treatment initiation.

Public health relevance
PROJECT NARRATIVE Depressive symptoms reduce the odds of quitting smoking by as much as 50-60%. Cessation treatments that actively target depression may improve smoking abstinence, but currently available options have low reach and, therefore, limited impact. Mobile health applications have greater reach and significant potential for delivering effective and impactful cessation treatments. The current study will provide a definitive test of Actify!, the first mHealth app designed to concurrently target depressive symptoms and smoking as a means of promoting tobacco cessation.